Organ system cross talk in ischemic heart disease

PROJECT SUMMARY/ABSTRACT
This proposal’s objective is to determine whether changing the signaling patterns between the skeletal stem
cells (SSCs) and hematopoietic stem cells (HSCs) can treat atherosclerotic cardiovascular disease (ASCVD).
Previous data from our lab suggests that aging SSCs can cause HSC inflammaging, defined as a skewing of
HSC progeny toward myeloid lineages that may be more dysfunctional, leading to the development of vascular
disease. Whether rejuvenating the SSCs can be used as a therapy in ASCVD remains unclear. Our long-term
goal is to develop novel therapy to reverse age-related ASCVD. Our central hypothesis is that the SSC
rejuvenation will rebalance HSCs and improve the function of their progeny that travel to the
vasculature in response to injury, preventing the progression of atherosclerosis. The rationale is that
previous work by our labs and others: 1) identified and characterized the existence of SSCs in mice and
humans, 2) demonstrated that transplantation of SSCs from aged mice cause inflammaging of HSCs in young
mice, 3) showed that HSC inflammaging contributes to ASCVD, and 4) observed that activated immune cells,
some of which originate from HSCs, contribute to plaque progression. Our work will enhance the understanding
of the cross talk between organs that contribute to ASCVD, paving the way for the development of novel
strategies for disease treatment. To test our central hypothesis and attain our objective, we propose the
following aims: 1. To characterize the effects of SSC aging on the vasculature (including the perivascular
fat). We hypothesize that aged SSCs skew HSCs toward dysfunctional myeloid progeny that promote ASCVD.
For this aim, we will first perform lineage tracing experiments. The expected outcome from the lineage tracing
experiments is that older mice with atherosclerosis have the highest proportion of HSC-progeny in their
vasculature. In our second set of experiments for Aim 1, we will determine whether HSC inflammaging induced
by aged SSCs contributes to atherosclerosis progression. We hypothesize that 2-month HSCs transplanted
into 20-month mice become aged and their progeny then cause atherosclerotic progression in pro-atherogenic
mice fed a high fat diet. We will perform cell transplantation studies to determine whether exposure to youthful
or aged SSCs affects atherosclerotic progression. We expect that young HSCs exposed to aged SSCs will
develop HSC inflammaging and contribute to plaque progression. Finally, we will compare the proteomic and
genomic signatures of these multiple organs in humans to confirm that SSC aging also contributes to human
atherosclerosis. 2. To determine whether targeted reversal of age-related decreases in BMP2 signaling
in SSCs can alter atherosclerosis progression. We hypothesize that BMP2 infusion or application of a BMP2
infused hydrogel to aged bones creates a more balanced HSC progeny, decreasing vascular inflammation and
preventing the progression of ASCVD. We will perform a randomized, control trial of local BMP2 treatment into
the bone marrow and measure its effects on plaque size and composition.

Public health relevance
PROJECT NARRATIVE We think that aging causes cells in the bone marrow to stop secreting proteins that support normal development of immune cells, the cells in the body that heal wounds. This causes abnormal immune cells to travel to the arteries and cause disease. In this project, we will reverse aging in the bone marrow and see if it can prevent disease in the arteries.